UCSC Graduate Program in Genome Sciences

ABSTRACT
The UCSC Graduate Training Program in Genome Science combines cutting-edge computational biology
training in a multidisciplinary biomedical science and engineering environment. Among other strengths, UC
Santa Cruz is a world leader in computational biology, bioinformatics, genomic technologies and RNA biology.
The goals of the program are to prepare trainees for advanced academic and industry careers in biomedical
genomics. Our training program develops critical thinking skills, provides rigorous hands-on training in computer
science, statistics, and biological sciences, and develops scientific communication skills.
The proposed program will provide support for six trainees, each with a two-year appointment. Our trainee
applicant pool consists of PhD students who have already joined UCSC’s interdisciplinary genomics and
biomedical sciences community and completed three hands-on laboratory rotations during their first year of
study, at least one of which must be conducted in the laboratory of a GS Program faculty member.
Genome Science trainees participate in several innovative training activities. Each year, our trainees will
organize and run a bootcamp for each year’s incoming PhD cohort of students who are accepted by the Dept.
of Biomolecular Engineering. This 10-day activity is designed and implemented by the T32 trainees with
feedback and guidance from faculty. The centerpiece of the bootcamp is an ambitious hands-on activity for the
incoming grad cohort to tackle. Previous activities have included building a functional DropSeq single-cell RNA
sequencing machine (2017), as well as genome sequencing and assembly of the banana slug – UCSC’s mascot
(2019). Trainees receive training in labs of 26 faculty, including a winner of the MacArthur Award, members of
the National Academy of Sciences, and a Nobel Laureate. Formal coursework for trainees includes graduate-
level instruction in bioethics, programming, practical genomics, statistics, and scientific writing. These courses
cover essential topics in rigor and reproducibility and responsible conduct of research. Working with the Graduate
Advising Committee and their faculty mentors, trainees develop Individual Development Plans which may involve
further coursework to address specific deficiencies or special interests. In coordination with the NHGRI DAP
program, trainees will also serve as mentors to undergraduate students.
Program success will be assessed via several quantitative metrics of trainee productivity, such as the timing
and number of publications and success in applying for extramural research funds, as well as career outcomes
that are tracked following the award of PhDs. These metrics will be assessed by the Genome Sciences
Executive Committee.
The program is interdisciplinary, including 26 program faculty from 8 departments. Most trainees and
approximately half of program faculty are affiliated with the Biomolecular Engineering Department, as nearly all
BME faculty have genomics-focused research programs.

Public health relevance
PROJECT NARRATIVE The UCSC Graduate Program in Genome Science is designed to train the next generation of scientific leaders in genome sciences, a discipline that is critical to development of new therapies—from cancer to heritable disease. UCSC has been a leader in genomics research since the field was founded and offers a rich interdisciplinary genomics training environment. Our program spans 26 training faculty from 8 departments and combines formal training in statistics, programming, and engineering with more traditional disciplines, such as molecular biology and genetics.